Combinatorial Targeting of Epigenomic and Microenvironmental Pathways to Suppress MAPK Inhibitor Resistance in Melanoma

ABSTRACT
Mutation-targeted small molecular inhibitors and immune checkpoint antibodies have extended the quality and
quantity of life for patients with advanced MUTBRAF melanoma. Development of combinations based on these
foundational therapies should yield further survival benefits in the near future. The combo of BRAF and MEK
inhibitors specifically suppresses a form of resistance driven mainly by genetic alterations that result in MAPK-
reactivation and restoration of MAPK-addiction. However, this clinically validated approach to suppress BRAF
inhibitor resistance does not address epigenomic and immunologic alterations that drive resistance via MAPK-
redundant and CD8 T-cell-depleted tumor states. We propose to uncover combinatorial targets in advanced
V600BRAF mutant melanoma by understanding MAPK inhibitor-induced epigenomic and immune-suppressive
mechanisms and their interplay. We hypothesize that MAPK inhibitor-induced tumor cell-intrinsic and extrinsic
adaptations, which have been linked to innate anti-PD-1 resistance, converge on the elaboration and actions of
TGFβ, BMP, or VEGFA in the tumor immune microenvironment.
The Lo Lab has a track record of integrating analysis of clinical and experimental resistance evolution to derive
translatable preclinical strategies to suppress resistance. We propose (Aim 1) to generate a landscape
perspective of epigenome-directed tumor cell-intrinsic resistance evolution by comparative analysis of human
melanoma cell lines, patient-derived xenografts and immune-competent murine melanoma models. This analysis
seeks to identify master transcriptional factors regulating phenotypic transitions to provide insights into
resistance-regulatory growth factors and signaling pathways. In Aim 2, we will test the hypothesis that MAPK
inhibitors induce adaptive epigenomic and immune-suppressive processes via elaboration of specific TGFβs or
BMPs. The action of these factors on the tumor cells and the tumor microenvironment will be analyzed,
respectively, by characterization of cis-regulatory enhancer or super-enhancer modules involving TGFβ/BMP
receptor-regulated SMADs and by single-cell RNA-seq of dissociated tumors. In Aim 3, we will evaluate the
efficacy and mechanisms of blocking TGFβ, BMP, or VEGFA on top of the MAPKi+aPD-L1 foundation and
dissect the influence of the most efficacious combination on single T-cell clonotypes and epigenetic states of
activation or exhaustion. Together, these studies will advance translation of our understanding of multi-faceted
resistance mechanisms into next-generation combinatorial therapies for advanced melanoma.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Therapeutic resistance is the rule rather than the exception and limits the clinical benefits of mutation-targeted and immune therapies for advanced melanoma. Translating cancer research into patient survival depends on a deep understanding of resistance mechanisms to clinically active therapies. As BRAF/MEK and PD-1 therapies were first developed in patients with advanced melanoma, rational strategies to combine these therapies carry far-reaching implications for cancer treatments in general.